Sensory neuron-mast cell crosstalk in IBS pathophysiology

PROJECT SUMMARY/ABSTRACT
Irritable bowel syndrome (IBS) affects ~9% of the worldwide population and is the most common outpatient
gastrointestinal diagnosis. Abdominal pain is the most important cause of morbidity in this patient population
and available treatments for abdominal pain in IBS are limited, untargeted, symptom-based, and often
ineffective. This is partly due to a lack of a better understanding of underlying pathogenic mechanisms and
poses a significant knowledge gap. Increased intestinal permeability and visceral hypersensitivity are key
pathogenic features in patients with IBS. However, what causes VH and barrier dysfunction in IBS is poorly
understood. Mast cells have been proposed as a key player in barrier dysfunction and visceral hypersensitivity
in IBS. However, several fundamental questions about mast cell activation remain unanswered which hinders
our understanding of barrier dysfunction and visceral hypersensitivity in IBS. Our preliminary data suggests
that the level of Substance P (released by sensory neurons) is increased in patients with diarrhea-predominant
IBS (IBS-D). This is accompanied by increased MRGPRX2 expression at mRNA and protein levels in patients
with IBS-D. Furthermore, our in vitro studies confirm that Substance P can activate colonic mast cells to
release disease-promoting mediators and in vivo studies suggest that Substance P-mediated activation of
MRGPRX2 plays a key role in visceral hypersensitivity and barrier dysfunction in IBS rodent models. Thus,
there is a critical need to delineate the role of Substance P and its receptor MRGPRX2 in IBS pathophysiology,
which would bring us closer to the goal of precision medicine targeting underlying pathophysiology rather than
the current symptom-based management of IBS. The long-term goal of this project is to advance our
understanding of VH and barrier dysfunction in IBS to build the foundational knowledge to develop effective
and targeted therapies for IBS. The objective is to delineate the underlying mechanisms of bidirectional
crosstalk between sensory neurons and mast cells in IBS and establish its role in IBS pathophysiology. The
central hypothesis is that Substance P-mediated activation of MRGPRX2 in colonic mast cells drives VH and
barrier dysfunction in IBS in a feed-forward cycle. In Aim 1, we will determine the role and mechanisms of
Substance P-mediated colonic mast cell activation in IBS using rodent colonic mast cell culture and human
colonic biopsies (from healthy control and IBS-D biopsies). In Aim 2, we will elucidate the contributions of
MRGPRX2-mediated mast cell activation to IBS pathophysiology in vivo using two validated rodent models.
Completion of these aims will provide fundamental insights into sensory neuron-mast cell interactions in IBS
and provide proof of principle for a future R01 proposal to definitively establish the role of Substance P and
MRGPRX2 in IBS pathophysiology, delineate the molecular mechanisms of SubstanceP-Mrgprb2 pathway
barrier dysfunction and visceral hypersensitivity and define the final part of crosstalk i.e. role of mast cells in
Substance P release in IBS.

Public health relevance
PROJECT NARRATIVE Abdominal pain is the primary driver of healthcare utilization by patients with irritable bowel syndrome (IBS), however, available treatments for abdominal pain in IBS are limited, untargeted, symptom-based, and often ineffective. This is partly due to a lack of a better understanding of underlying pathogenic mechanisms. The overall goal of this project is to delineate the mechanisms of how sensory neuron-mediated activation of MRGPRX2 receptor on a subset of colonic mast cells contributes to visceral hypersensitivity and barrier dysfunction in IBS, thereby identifying a novel pathway for therapeutic target and an IBS subpopulation who will benefit from this targeted treatment.